Milk Type in Toddlers (Milk-TOT) Study: Impact of Whole versus Low-fat Milk on Child Adiposity, Health and Development

1 Abstract
2 The prevalence of child obesity in the U.S. has tripled since the 1970s and excess weight gain – even in young
3 children – is a precursor to adult obesity and associated co-morbidities. In the U.S. it is recommended that
4 children consume whole cow’s milk (3.5% fat) from ages 1 to 2 years to support rapid early growth and brain
5 development, and then at age 2 years transition to low-fat (1%) or non-fat milk to reduce saturated fat and
6 calorie intake. Surprisingly few rigorous trials support recommendations regarding the optimal amount of fat in
7 milk. Paradoxically, existing observational studies suggest that lower fat milk consumption is associated with
8 increased adiposity in children. The effects of the types of fat found in milk on cardiometabolic disease risk
9 have also been questioned. We propose a randomized controlled trial to evaluate the effect of consumption of
10 whole versus 1% milk on child adiposity and other health and developmental outcomes beginning after
11 toddlers have successfully transitioned from breastmilk and/or formula to cow’s milk at 2 years of age. For the
12 proposed trial, Milk Type in Toddlers (Milk-TOT) Study, we will recruit 625 parents of toddlers and randomly
13 assign them to either whole or 1% milk groups for 1 year. Our primary aim is to determine how milk fat type
14 (whole versus 1%) consumed from age 2 to 3 years affects change in adiposity as measured by waist-to-height
15 ratio (primary outcome), and body mass index z-score, tri-ponderal mass index, and waist circumference z-
16 score (secondary outcomes). Secondary aims are to evaluate how milk type consumed from age 2 to 3 years
17 affects changes in milk, total and saturated fat, added sugars, total energy intake and overall diet quality, as
18 well as blood lipids, glucoregulatory indices, vitamin D status, and neurocognitive development. An exploratory
19 aim will assess changes in gut microbiota. Results from the Milk-TOT Study will inform evidence-based
20 recommendations about the optimal milk fat that children need to optimize their growth, development, and
21 health. Such recommendations will influence healthcare provider advice about the type of milk that children
22 consume as well as inform federal nutrition programs that collectively provide milk to half of young children in
23 the U.S.

Public health relevance
Project Narrative In the U.S. it is recommended that young children consume whole-fat cow’s milk when they are 1 year old and then transition to low-fat (1%) or non-fat milk beginning at age 2 years to reduce calorie intake for obesity prevention. However, these recommendations are not based on rigorous trials, and the existing observational studies suggest that higher fat milk consumption throughout childhood may in fact be associated with reduced adiposity. To inform dietary recommendations and federal nutrition policy, we propose a 1-year randomized controlled trial to test the impact of milk type (whole versus 1%) on adiposity (waist-to-height ratio, body mass index, tri-ponderal mass index, and waist circumference), dietary intake (energy, total and saturated fat, added sugars, overall diet quality), vitamin D status, cardiometabolic health (blood lipids, glucoregulatory indices), neurocognitive development, and microbiota, based on baseline and follow-up assessments in 500 children followed from 2 to 3 years of age. 1